Expanding single-cell transcriptomics to chart the role of noncoding RNAs in normal hematopoiesis

PROJECT ABSTRACT
Hematopoietic stem and progenitor cells (HSPCs) carry the important responsibility of producing an enormous
number of myeloid and lymphoid cells. Defects in HSPC function can lead to benign and malignant neoplasms
as well as bone marrow failure, often driven by somatic mutations in key regulators. Noncoding (nc)RNAs are
emerging regulators of hematopoietic self-renewal and lineage specification. Long (l)ncRNAs specifically
contribute by modulating genome topology, chromatin compaction, gene transcription, post-transcriptional
processing, translation, and cellular signaling. In addition, transfer (t)RNAs, which shuttle amino acids to the
ribosome, shape the cellular proteome by enhancing the translation of messenger RNAs enriched for cognate
codons. When dysregulated, these ncRNAs contribute to the pathogenesis of hematologic neoplasms. Despite
these advances, ncRNAs are not profiled in standard single-cell RNA sequencing (scRNAseq): ncRNAs are
mostly not endogenously polyadenylated (EPA), preventing their capture by oligo-deoxythymidine primers. This
limitation of scRNAseq critically prevents the study of how ncRNAs bias and commit cells toward hematopoietic
lineages. We hypothesize that ncRNAs, particularly lncRNAs and tRNAs, bias HSPCs toward specific cellular
fates. To test this hypothesis, we developed a method, single-cell total RNA sequencing (scTRS), that
incorporates RNA de-modification and exogenous polyadenylation to extend RNA capture to modified and non-
EPA ncRNAs, which are not captured by other methods. Here, first, I aim to develop a computational pipeline to
enable the processing and analysis of scTRS data. Second, I will apply scTRS in primary HSPCs to identify
candidate ncRNA drivers of normal hematopoiesis. Then, I propose a series of in vitro perturbation experiments
to validate and examine the roles of these candidate drivers of normal differentiation. Finally, because the scTRS
workflow is compatible with commercially available droplet-based platforms and the computational pipeline will
be broadly shared, scTRS will be available to research groups across fields for broad impact. Collectively, this
work will deliver novel and actionable insights into how ncRNAs help orchestrate human hematopoiesis.

Public health relevance
PROJECT NARRATIVE Noncoding RNAs are emerging regulators of normal hematopoiesis, affecting hematopoietic self-renewal, function, and lineage commitment. While single-cell RNA sequencing (scRNAseq) has enabled the precise study of individual hematopoietic gene expression programs, our ability to analyze how noncoding (nc)RNAs bias and commit cells toward hematopoietic fates has been hampered by the fact that scRNAseq only profiles endogenously polyadenylated RNAs such as messenger (m)RNAs, which excludes most ncRNAs. In this proposal, I will focus on developing methods and a computational pipeline for single-cell “total” (mRNA + ncRNA) RNAseq (scTRS), applying these methods to mobilized peripheral blood cells from healthy individuals, and identifying and validating candidate transfer RNA and long ncRNA drivers of hematopoiesis to provide our first comprehensive, single-cell examination of how ncRNAs drive normal hematopoiesis.